HIV, ART and aging: Role of Lactate in NeuroHIV

PROJECT SUMMARY/ABSTRACT
People living with HIV (PLWH) in the current era of effective combination antiretroviral therapy (cART) experience
significant burdens as a result of HIV-related neurocognitive disorders (HAND/NeuroHIV). This is partially due to
cART’s impact on the lifespan of PLWH, as they now live longer with co-morbidities such as aging. Our
preliminary studies show enhanced lactylation has been observed in younger SIV-infected nonhuman primates
(NHPs) compared to older ones and in SIV-infected NHPs on ART. This suggests that lactate may play a critical
role in contributing to the pathogenesis and progression of HAND. Extant research shows that metabolites from
glycolysis and the tricarboxylic (TCA) cycle, particularly lactate, play crucial roles in post-translational
modifications like histone lactylation, which can regulate gene expression and stimulate inflammatory pathways.
Additionally, studies show SIV infection in NHPs causes gut microbiome dysbiosis of lactate metabolizing species
such as Lactobacillus and also that HIV protein Tat down-regulates lactate production in astrocytes, while
microRNA-29b may regulate lactate metabolism and contribute to HAND progression, underscoring the need for
further investigation into these mechanisms. We hypothesize that age, premature aging, and lactate-mediated
lactylation play a significant role in developing and progressing HAND/NeuroHIV in PLWH. In Aim 1, we will use
an NHP model of SIV infection with ART to test this hypothesis by examining lactate levels in plasma and CSF,
as well as MRI scans to assess spatial memory of two groups of rhesus macaques (one young, one old) until
necropsy. At necropsy, changes in lactylation levels and synaptodendritic injury in the prefrontal cortex and
temporal lobe will be analyzed using immunohistochemistry and global proteomics. In Aim 2, we will use the
same study design as Aim 1 and treat a subset of both groups with probiotics three months before necropsy to
identify the effect of probiotic-derived lactate in HAND progression. In Aim 3, we will examine how microRNA-
29b impacts the regulation of lactate production in human iPSC-derived astrocytes, microglia, and neurons using
extracellular vesicles (EVs) isolated from Tat-treated astrocytes and HIV-1 infected microglia to analyze lactate
production and its impact on neuronal survival and neuronal metabolism using SeaHorse technology. The
proposed studies aim to investigate the interplay between aging, lactate-mediated lactylation, and the
progression of HAND in PLWH. Our long-term objective is to identify novel therapeutic strategies to mitigate
HAND, an untreatable condition significantly impacting this population's neurological health. We will integrate
metabolic profiling, proteomics, histological techniques, and advanced imaging to comprehensively assess the
mechanisms underlying HAND and the potential therapeutic benefits of lactate modulation for PLWH. Successful
completion of this work could lead to innovative strategies that enhance metabolic health and neurological
outcomes for PLWH, improving their overall quality of life.

Public health relevance
PROJECT NARRATIVE People living with HIV in the current era of effective combination antiretroviral therapy (cART) have mild forms of neurocognitive impairments (NeuroHIV). Our nonhuman primate studies will elucidate the roles of aging and lactate, alongside persistent inflammation associated with SIV infection and ART, in the development and progression of NeuroHIV. We will also examine human astrocytes and neurons to determine how microRNA- 29b regulates lactate production, improving our understanding of the long-term consequences of HIV infection and informing interventions such as lactate supplementation to treat NeuroHIV and enhance the quality of life for affected individuals.